Uncovering Central Regulators of Neural Stem Cell Aging and Rejuvenation

Project Summary/Abstract
As the incidence of Alzheimer’s disease (AD) continues to increase and drugs targeting traditional disease
etiology have thus far failed, it is critical to approach this devastating disease from different perspectives.
Neural stem cells (NSC) have thus emerged as a potential therapeutic. Neural stem cells (NSCs) play a critical
role in learning, mood, and memory by continuing to generate newborn neurons throughout life in the dentate
gyrus of the hippocampus. This process of neurogenesis is impaired early in age and in Alzheimer’s disease.
In addition, NSC numbers are correlated with AD outcome in humans and modulation of neurogenesis in
mouse models can contribute to cognitive impairment or improvement. Thus, there remains a need to
understand why NSC become dysfunctional and how to rejuvenate them for therapeutic use. To address these
questions, we performed single-cell RNA sequencing upon young and old NSCs. We uncovered a gene
network that older NSCs are unable to activate. Our lab discovered a compound predicted to activate this
gene network and tested it in old mice. This compound can sustain high levels of NSC activation while
increasing NSC pool size, neurogenesis, and cognition. These effects are unforeseen in NSC biology and
reveal a novel regenerative capacity of NSCs without triggering depletion nor deepened quiescence. My
preliminary data suggest that this drug uniquely targets a chromatin remodeling factor that is central in this
identified gene network. Correlative evidence and existing literature further support this. Thus, I hypothesize
that knockdown of this factor in young mice via lentivirus will recapitulate phenotypic effects of NSC aging (Aim
1) whereas overexpression of this factor is sufficient to promote NSC rejuvenation (Aim 2). This would provide
support our compound works through targeting this factor and would establish mechanistic understanding of
why NSCs decline in age and how to target them for rejuvenation in Alzheimer’s. The extensive use of
immunohistochemistry, surgical techniques and associated computational training establish this project as an
ideal training opportunity. This training plan incorporates acquisition of diverse skills in stem cell biology and
neuroscience, specialized coursework in bioinformatics, the honing of presentation and writing skills, and
career development that will help me achieve my goal of becoming a successful independent scientist in brain
aging. My mentor, Dr. Michael Bonaguidi, has an exceptional training record and has been instrumental in the
neurogenesis and NSC field. The Bonaguidi lab is located within the rapidly growing Broad Stem Cell Institute
at USC, which is a highly collaborative and dynamic environment for my scientific development.

Public health relevance
Project Narrative Stem cells are a critical aspect of aging as decreased stem cell capacity can contribute to age- related diseases, such as neural stem cells in the brain predisposing the hippocampus to Alzheimer’s. Therefore, understanding neural stem cell aging will provide opportunities to harness neural stem cells as a therapeutic for age-related cognitive decline and dementias like Alzheimer’s. This proposal will uncover central mechanisms of how neural stem cells decline with age and will reveal how to target them therapeutically.